ARTHRITIS, MUSCULOSKELETAL, &SKIN DISEASE

Under this contract, the Contractor will provide logistical and administrative services in support of the activities of the Congressionally mandated National Arthritis and musculoskeletal and Skin Disease Information Clearinghouse. Additionally, the Contractor will provide support services for other NIAMS information dissemination efforts.